Vanderbilt Integrated Center of Excellence in Maternal and Pediatric Precision Therapeutics (VICE-MPRINT)

PROJECT SUMMARY
Our data building system, EHR2PKPD, is efficient, modular, and designed to evolve. The modules were
originally developed using data extracted from the locally-developed EHR system, called StarPanel, at
Vanderbilt University Medical Center (VUMC) for adult (non-pregnant) patients. On 11/2/2017, VUMC
transitioned to an Epic EHR system and implemented a common data model, Observational Medical
Outcomes Partnership (OMOP). Thus, the way data are recorded and the data format at VUMC changed
substantially. These changes introduced significant challenges in applying our EHR2PKPD system to
generate drug dose data from our current VUMC EHRs. We also recognize the drugs and dosing
decisions for pregnant and lactating women and children are often unique. In collaboration with other
sites at the Maternal and Pediatric Precision in Therapeutics (MPRINT) Hub, we will make our drug
research data building system more widely applicable to other types of EHRs at other institutions.
Using two drugs for pregnant and lactating women and two drugs for children, we will test and revise our
EHR2PKPD system. We propose to achieve two aims: (1) to establish drug dose data processing and
building modules of EHR2PKPD for data extracted from VUMC Epic EHR system; (2) to test and
generalize drug dose data processing and building modules of EHR2PKPD for data extracted from non-
VUMC EHR system. We will focus on structured data, as structured dose data are useful to perform
drug-related research for many drugs, while this task is achievable during this 1-year funding period.
Working with unstructured dose data will be the focus of future collaborative research work with other
sites at the MPRINT Hub. This work will provide the foundations for developing a maternal and pediatric
translational research resource platform, which will ultimately facilitate filling knowledge gap in maternal
and pediatric therapy.

Public health relevance
PROJECT NARRATIVE We have been developing a general purpose system, called EHR2PKPD, for building datasets to perform drug-related studies using EHRs in a more efficient and robust way, which was originally developed using adult (non-pregnant) patient data extracted from the locally-developed EHR system at Vanderbilt University Medical Center (VUMC). We now expand our system to build drug dose data, specifically focusing on pregnant and lactating women and children, which can be also applicable to other types of EHRs at other institutions. This work will lay the foundations for developing a maternal and pediatric translational research resource platform, and ultimately facilitate filling knowledge gaps in maternal and pediatric therapy.